Implementing genomic medicine through pragmatic trials in diverse and underserved populations across Indiana.

The promise of genomic medicine to transform healthcare and improve health will not be fully realized until
discoveries become relevant to and available for use by diverse populations and their clinicians. Chronic
kidney disease (CKD) is associated with hypertension. People with African ancestry (AAs) have the highest
risk of CKD and kidney failure, the highest prevalence of hypertension, and the lowest rate of blood pressure
(BP) control. While this disparity is in part due to social determinants, ancestry has biological underpinnings
and APOL1 high-risk genetic variants, nearly exclusive in AAs, increase kidney failure risk 10-fold. As part of
the IGNITE II network, we will continue to conduct the prospective randomized pragmatic genotype-guided
clinical trial, GUARDD-US, to determine the impact of implementing APOL1 and antihypertensive
pharmacogenomic testing on hypertension control. The trial will determine the effect of early vs. delayed
knowledge of a positive APOL1 genotyping result on 3-month systolic blood pressure (SBP). The trial aims to
recruit African Americans with hypertension, with or without CKD, randomized to immediate versus delayed
return of APOL1 genetic testing. In those who are APOL1 negative, we will also conduct a pilot study to test
the impact of pharmacogenetic (PGx) testing on SBP. Secondary outcomes include 6-month SBP, in CKD
patients, on medications ordered, renal diagnosis and testing patient psycho-behavioral outcomes, cost
effectiveness, and the effect of PGX guided hypertension management on SBP. We expect the successful
results from this clinical trial will provide critical evidence needed to drive the implementation of genomic
medicine across broad demographics of patient populations.

Public health relevance
Hypertension affects large percentages of the population and identifying the optimal medication for an individual can be challenging, the GUARDD-US this trial will determine whether using genetic information to inform selection of antihypertensives leads to better clinical outcomes for patients. People with African ancestry (AAs) have the highest rates of uncontrolled high blood pressure, chronic kidney disease and kidney failure, some of which is due to APOL1 genetic variants. We will test AA adults with high blood pressure for APOL1 and return the results to patients and their clinicians, to see if early knowledge of high genetic risk improves blood pressure, provider and patient behaviors and is cost effective.